CEIRS Influenza Data Processing and Coordinating Center (DPCC)

The Influenza Data Processing Center will provide processing for data collected and generated by the NIAID Centers of Excellence in Influenza Research and Surveillance (CEIRS).